EXERCISING TOGETHER: A randomized controlled trial of partnered exercise training on the health of couples coping with cancer

Prostate (PC), breast (BC) and colorectal (CRC) cancer are the most common and survivable cancers; most
survivors of these cancers will be married when diagnosed. Compared to couples that aren't facing a chronic
illness, both cancer survivors and their spouses suffer from poorer physical and mental health and higher
mortality. Cancer often disrupts the marriage and declines in relationship quality are linked to shorter survival.
Exercise has been shown to offer symptomatic relief from side effects of cancer treatment and improve quality
of life among cancer survivors; but, has not been used to simultaneously improve the physical and mental
health of survivors and spouses and protect the marriage by adapting it to be a shared, team-based activity.
Our pilot study of a novel partnered exercise program, Exercising Together, has shown preliminary feasibility
and acceptability, but was limited to couples facing PC and fitness outcomes. We propose a larger, more
rigorous evaluation of Exercising Together expanding the sample to include couples coping early on with other
common cancers, measuring clinically relevant outcomes and including comparison groups that will allow us to
distinguish the unique benefits of partnered training on individual and couple health from the possible benefits
of exercising in a group with others and/or of engaging both partners in a new health behavior. We plan to
conduct a 3-arm, single-blind, parallel design, randomized trial in 294 couples (N=588 participants) coping with
PC, BC or CRC, aged 40-70 years old and within 2 years of completion of primary treatment for cancer. Our
study compares couples randomized partnered strength training (Exercising Together) in a supervised group
setting to (Arm 2) separate supervised group exercise (survivor-only and spouse-only classes) and (Arm 3)
separate unsupervised exercise where survivors and spouses exercise on their own at home. Couples will train
2x/wk for 6 months with a 6-month follow-up. The aims of this study are to determine the efficacy of Exercising
Together on 1) relationship quality in couples coping with PC, BC, or CRC, 2) physical (body composition,
lipids, insulin resistance, blood pressure, inflammation, physical function) and mental (anxiety, depression, fear
of recurrence) health of both the survivor and spouse and to evaluate the sustainability and interdependence of
benefits from Exercising Together. This study is relevant to public health because the number of cancer
survivors and caregivers in the healthcare system will double by 2050, yet there are no programs whatsoever
that address the triple threat that cancer poses to the physical and mental health of both survivors and spouses
and to their marital relationship. We are the first to focus on the interdependent nature of the couple through
partnered exercise that promotes relationship building making this program unlike any other. Exercising
Together is a completely new approach to cancer survivorship because it considers the health of the survivor
and his/her spouse and their relationship as equally important targets. If successful, this unique approach
could be applied to survivors of other cancers or diseases increasing the potential impact of this study.

Public health relevance
Relevance Of the 14.5 million cancer survivors in the U.S., most are married. Cancer threatens quality of life and mortality of survivors and their partners and strains their marriage. The proposed trial of partnered exercise training aims to simultaneously improve physical, mental and relationship health among married couples coping with cancer.